The National Health and Aging Trends Study

Project Summary
The purpose of this application is to extend and enhance the National Health and Aging Trends Study (NHATS),
a national platform for studying late life disability trends and trajectories. The overall aims of NHATS are to 1)
promote scientific inquiry into late-life disability trends and dynamics, their antecedents and correlates, and
disparities therein and (2) to advance study of the social and economic consequences of late-life disability for
individuals, families, and society. To achieve these aims in the next five-year cycle, we will continue the unique
key design features of NHATS including collecting data annually and in person from a nationally representative
sample of older adults (sampled from the Medicare enrollment file) in 2019-2023 (Rounds 9-13). We will also
add several innovative enhancements focused on objective measures of cognitive and sensory capacity and
physical activity. Extending NHATS in this way will allow important scientific questions to be addressed
concerning both shorter and longer-term in-depth trends in components of the disability process, as well as the
dynamics of disability onset, progression and recovery. Specifically, in the next cycle NHATS will 1) Continue
collection of the enhanced disability protocol and supplemental questions on disability antecedents and
consequences including subjective and economic wellbeing, living and care arrangements, and quality of end of
life; and replenish the sample in Round 10 (2020) in order to maintain NHATS' ability to produce 5-year age
estimates (up to 90+) and Black-White comparisons; 2) Enrich and expand measurement in the NHATS' annual
disability protocol including development and implementation of a) a new iPad-based protocol to enhance
measures of cognitive and sensory capacity; and b) a panel substudy of physical activity using accelerometry;
and 3) Document and disseminate NHATS data, make available linked claims files and new policy-relevant
linkages, and provide new training opportunities to the growing NHATS user community. These aims will allow
NHATS to achieve its overarching goal of providing a platform for scientific inquiry to guide efforts to reduce
disability, maximize functioning, and enhance older adults' quality of life.

Public health relevance
Project Narrative NHATS is a national study of late-life disability designed as a platform for researchers on aging to engage in scientific inquiry to guide efforts to reduce disability, maximize functioning, and enhance older adults' quality of life.